Biosynthetic and self-resistance investigations of kibdelomycin.

The need for new antibiotic drug leads is pressing given the appearance of multidrug resistant (MDR)
and extremely drug-resistant (XDR) strains of pathogenic bacteria. Kibdelomycin is a natural product
produced by Kibdelosporangium sp. (MA7385) and Amycolatopsis sp. FERM BP-11411 and was
previously identified to have a new binding motif to DNA gyrase, in part due to interesting structural features
found in the molecule, and a low frequency of resistance making it an excellent lead compound for the
development of Gram-negative antibacterial agents. Kibdelomycin represents an exciting platform that can
be used for the discovery of lead compounds for the treatment of antibiotic resistant bacterial infections. In
this R21 application, we propose a two-pronged approach to investigate the biosynthesis of kibdelomycin
with the ultimate goal of creating kibdelomycin variants that have a greater activity against Acinetobacter
baumannii and Pseudomonas aeruginosa, two bacterial pathogens that the Center for Disease Control
classifies as urgent and serious threats, respectively. In Aim 1.1, we propose to develop a genetic system
for Amycolatopsis sp. FERM BP-11411 in analogy to our team’s previous success in Amycolatopsis
mediterranei S699. This will provide access to kibdelomycin variants that are difficult to access via
synthesis. In Aim 1.2, we propose to investigate the early biosynthetic steps of how kibdelomycin is
assembled by a bottom-up synthetic biology approach synthesizing constructs to produce early
intermediates that can be used in analog synthesis. In Aim 2, we engage in a complementary approach to
study the natural resistance of the producing strain Kibdelosporangium sp. (MA7385). These self-
resistance studies will help dissect the amino acid substitutions present in the kibdelomycin-resistant DNA
gyrase to preemptively understand how resistance might evolve in clinical bacterial strains and to guide
future synthetic investigations into analogs that can avert this outcome.

Public health relevance
Difficult to treat microbial infections are becoming more common due to an increased prevalence in drug resistance amongst microorganisms and can result in staggering negative effects, both human and monetary. New drug leads are desperately needed to treat these drug resistant infections and this proposal details the biosynthetic investigations into the broad-range antibacterial kibdelomycin. Given the novel binding of kibdelomycin to DNA gyrase, an antibacterial target, with no cross-resistance to currently used antibiotics, we expect to generate drug leads to deal with this upcoming health crisis.